Optimizing Chest Compressions for Bradycardia during Neonatal Resuscitation

ABSTRACT
The result of birth asphyxia is a huge burden on global health contributing to 1 million neonatal death each year.
The current recommendations by the neonatal resuscitation program (NRP) to provide external chest
compressions when a newborn’s heart rate remains below 60 beats per minute after providing effective external
breaths for 30 seconds. This protocol is based on expert opinion, but not evidence. The objective of this proposal
is to determine the heart rate range for starting external chest compression to optimize blood flow to the brain
and the heart. Low heart rate at birth in a newborn is normally due to impaired gas exchange, and our preliminary
studies show that performing external chest compressions (CC) could be harmful when the heart is still beating.
We hypothesize that continuing external breaths for low heart rate (<60 per minute), along with medications like
epinephrine and only initiating external cardiac compressions if there is a loss of pulse/heart rate. This approach
could improve gas exchange, leading to better cerebral and myocardial perfusion, reducing time to establish a
heart rate of ≥ 100 per minute, and decrease brain and heart injury. Our specific aims will help determine the
best heart rate cut-off (HR 60-40 or 40-20bpm) for initiating external compressions using both a preterm and
term lamb model by evaluating:
1. Gas exchange and blood flows to brain and heart;
2. The loss of intrinsic heart beat when external chest compressions are performed and time taken to
achieve the desired heart rate;
3. The role of CC on cerebral and cardiac injury.
We can measure coronary blood flow directly which has not been reported before, which will help establish
normal and abnormal blood flow to the heart during transition and the influence of performing external chest
compressions, which is a novel observation. The proposed research is significant to find out, if the current method
of providing neonatal resuscitation, which is not evidence based, could be improved. Using a combination of
hemodynamics, biomarkers and imaging techniques, these data could be translated to direct neonatal
resuscitation. Use of electrocardiogram in the delivery room to detect heart rate has increased the frequency of
providing chest compressions by 3-fold, and may be causing more damage if over used. It is also possible that
resuscitation in preterm bradycardia could require different treatment protocols than at term gestation. It is
important to understand the risk of brain and cardiac damage involved with the current practice. Focusing on
providing external breaths with chest compressions when needed, with the objective to limit cardiac and asphyxia
brain injury will have a great impact globally during resuscitation of 1.4 million newborns each year.

Public health relevance
NARRATIVE The proposed research is critical for public health as the practice of providing external chest compressions in newborn when their heart rate is low at birth lacks evidence and could influence the outcome of neonatal resuscitation. Exploring the current and alternate strategies to improve oxygenated blood flow to brain & heart, and provide optimal support while limiting injury during external chest compressions may provide evidence that can improve newborn care. The current proposal is extremely relevant to current NIH/NICHD’s mission of protecting and enhancing the lives of newborn/children by optimizing the current practice of performing external chest compressions during neonatal resuscitation.